Modernizing, Expanding, and Measuring the Impact of FDA Food Safety Initiatives

Project Summary:
Modernizing, Expanding, and Measuring the Impact of FDA on Food Safety
Initiatives
In this CoAg we plan to take advantage of the alternative technologies developed to keep
augmenting the availability of high-quality training opportunities to support the FSMA‘s
Produce Safety Rule and other Rules implementation. These findings led to the
development of the Growing Safe Produce"/ "Produciendo con Inocuidad which was tested
by JIFSAN and promoted in the second Cooperative Agreement. A previous study from
IICA discovered the wide availability of mobile phones and internet usage throughout the
Americas, and we will continue to leverage these findings.
We will continue developing videos, web- and app-based training materials that not only
incorporate requisite training per the curriculum but also provide easy links to relevant
portions of the Rule and other important documents so that the user can refresh their
knowledge.
This approach will take advantage of the prevalence of access to mobile technology
throughout the Americas to create a group of tools that address the needs of adult learners
and non-traditional students. We will use well-tested approaches and learning techniques
to ensure sustainable knowledge building and understanding around FSMA
implementation. Working with partners in academia, we will measure the outreach of the
materials through descriptive statistics and develop case studies to measure impact.

Public health relevance
Project Narrative: With this new cooperative agreement, we intend to build upon the previous activities to help farms and facilities get an accurate message about the Food Safety Modernization Act (FSMA) regulations and adopt and implement the Rules that pertain to them. The overall goal is to help exporters in Latin America strengthen their food safety programs in order to export safer food and comply with the United States food safety regulations. IICA has the capacity to implement many outreach and innovative capacity building activities relying on its extensive network of professionals trained under current and previous projects related to FSMA and food safety. IICA can find the most appropriate location/users (specific countries/farms, etc.) for any programs and, as appropriate, align with or consider ongoing and planned training by other organizations as part of the context for this proposal. IICA can work and conduct outreach with government, academia, and the private industry. These capabilities have brought success to the previous two cooperative agreements between FDA and IICA. Through this project, we will use innovative and well- tested approaches, new learning techniques, and robust evaluation to ensure sustainable knowledge building and improved understanding around FSMA implementation and compliance. Tracking